Extending a Risk-taking Model of Alcohol-facilitated Consensual and Sexually Coercive Hook-up Behaviors Using a Daily Diary Design among College Men

Project Summary/Abstract
Hook-up behaviors (HUBs; i.e., sexual activity outside an exclusive relationship with no mutual
expectation of romantic commitment) are a prevalent problem on college campuses partly due to their association with
alcohol use and sexual assault. HUBs and sexual assault frequently co-occur, and HUBs are positively
associated with college men’s sexual assault perpetration. Prior research supports the relationship between alcohol
use and HUBs, as well as sexual aggression perpetration; however, there is limited understanding into individual
difference factors that increase the risk of alcohol-facilitated consensual and coercive HUBs. Alcohol Myopia
Theory (AMT) suggests alcohol intoxication creates a narrowing of attention to salient environmental factors
(e.g., rewarding sexual experiences). The dual systems model of risk-taking suggests that socio-emotional
system factors such as positive urgency (i.e., a tendency to give into impulses when positive affect is high) and the
expectation that alcohol use will result in positive sexual outcomes, such as heightened intimacy and/or arousal,
(i.e., alcohol-related sexual expectancies) increases sexual risk-taking. An integrated AMT and dual systems
model would suggest that the risk of alcohol-facilitated HUBs may depend on the presence of distal
socio-emotional system factors that increase the likelihood of sexual risk-taking behaviors. The overall objective of the
proposed study is to elucidate the temporal associations between alcohol use and engagement in consensual
and coercive HUBs among college men, and to identify the moderating effects of positive urgency and alcohol-
related sexual expectancies, utilizing a daily diary design. No prior research has examined the relationship
between college men’s alcohol use and HUBs and whether positive urgency and alcohol-related sexual
expectancies moderate the temporal association between alcohol and HUBs. Guided by the dual systems model and
AMT, the proposed study will advance the understanding and prevention of sexually risky behaviors. The specific
aims of this proposed study are to: (1) evaluate whether trait positive urgency moderates the temporal
association between alcohol use and HUB and (2) evaluate whether alcohol-related sex expectancies moderate the
temporal association between alcohol and HUBs. The proposed study will examine these factors in 250 college
men as they relate to the under-explored sexual activity of HUBs, utilizing an innovative daily diary design. The
proposed study is significant because it will inform researchers and prevention and intervention programs by
identifying specific risk factors to address in the prevention of alcohol-facilitated consensual and coercive HUBs.

Public health relevance
Project Narrative This project will examine the impact of alcohol use on consensual and sexually coercive hook-up behaviors using an innovative daily diary design. The proposed investigation will carry implications for the reduction of alcohol-related sexual risk-taking, including hook-up behaviors and sexual aggression, by providing information on critical risk factors. Thus, the proposed research is relevant to the prevention and treatment of sexual risk-taking, including sexual assault.